Algorithms for atomic-resolution structure identification of nanocrystals

Atomic-resolution structure identification of nanocrystals by graphene liquid cell electron microscopy (GLC-EM) has revealed that small, solubilized platinum nanocrystals consist of an ordered crystalline core surrounded by mobile surface atoms, which dissociate during oxidative etching, resulting in distinct temporal structural states. The number of structural states that can be resolved been limited by the requirements imposed by the 3D reconstruction algorithm. We developed a regularized 3D reconstruction algorithm that exploits the redundancy inherent in the experimental data, allowing us to improve the time resolution. Our developments provide a comprehensive molecular picture at unprecedented spatial and temporal resolution of the nonlinear, linear, and fluctuating dynamic phenomena that single nanocrystals undergo during the GLC-EM experiment. We determined atomic structures of 66 temporal structural states, extracted from 15 time-trajectories of individual nanocrystals. Large (478-698 atoms) and small (<300 atoms) nanocrystals show etching that preserves a stable core, whereas mid-sized (351-571 atoms) nanocrystals present dynamics that change the coordination of the core.